Nuclear transport of developmental signaling effectors

PROJECT SUMMARY
Heterotaxy, a disorder of left-right development, can be a severe cause of congenital heart disease, which has
poor morbidity and mortality even with advancements in surgical and medical management. TGF-β signaling
via SMADs is critical to establishing the left-right axis. For SMADs to alter gene transcription and affect
embryonic development, they must enter the nucleus. While the mechanism of how SMADs enter the nucleus
has been addressed long ago, we feel that a re-examination is necessary. Nuclear transport requires three
main elements: 1) Ran dependence, 2) Nuclear Transport Receptor, and 3) NLS (nuclear localization signal) or
NES (nuclear export signal) sequences on the cargo. Only recently have we discovered the entire repertoire of
NTRs, and in many cases, the tests for requirement and sufficiency for NLS and NES sequences have not
been met in SMAD signaling. Part of this logjam is due to the challenges of interrogating the nuclear transport
step given the signaling state of the cell, different binding partners, and other functions/interactions with
complex signaling networks. We have developed an innovative system using yeast to overcome this barrier.
Yeast has a highly conserved nuclear transport system with humans but lacks all of the signaling components
of the TGF-β pathway, allowing us to focus on just the nuclear transport step. Exploiting this “minimal system,”
we have created an innovative way to test all of the NTRs in vivo using the yeast system and test deletion
constructs of the SMADs to localize the NLS/NESs. Finally, our proposal is innovative because of the unique
collaboration of developmental biologists, nuclear trafficking experts, and nuclear receptor structural biologists.
We propose two Aims: Aim 1 – we will use our yeast system to screen the SMADs for NLS and NES
sequences and the critical NTRs that mediate their transport using our innovative rapamycin-inducible NTR
depletion strategy and then validate the NTRs for SMAD signaling using F0 CRISPR in Xenopus and test
deletion and point mutants for NLS and NES activity using Xenopus functional assays; Aim 2 – we will screen
the NTRS for SMAD direct binding and determine the atomic structure of the complex. In this way, each Aim
independently screens the SMADs for NLS and NES sequences and relevant NTRs, exploiting the strengths of
each system and minimizing the weakness of any one system with redundancy in the others. Finally, with
atomic structure, we intend to identify specific interaction sites that dictate NTR binding that could be the target
of small molecule disruptors, providing an avenue for therapeutics. Our multidisciplinary collaborative approach
should provide synergy within the Aims and create a multi-pronged attack on a fundamental problem in
developmental signaling that has important implications for a host of diseases, including cancer.

Public health relevance
PROJECT NARRATIVE Congenital heart disease, or “holes in the heart,” is a major cause of infant death in the US. Signals called the SMADs are critical for forming the heart during embryonic development. In this proposal, we will examine how the SMADs enter the nucleus of a cell to change gene expression and regulate heart development.